Center for Biomolecular NMR Data Processing and Analysis

The Center for Biomolecular NMR Data Processing and Analysis is a Biomedical Technology Research Resource that provides hundreds of software packages and computational resources to thousands of biomedical researchers. The NMRbox platform developed and operated by the center fosters software discovery, software persistence, a stable environment for meta-software development, a data lake with instances of important biomolecular data resources, and provides access to high-performance computational resources. We propose to acquire additional computational resources to support both a growing user database and increasingly demanding computational analyses.

Public health relevance
The Center for Biomolecular NMR Data Processing and Analysis proposes acquisition of computational resources to provide support the expanding user base for computationally demanding analyses.